Cardiovascular Risk Prediction and Reduction in Men with Prostate Cancer

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading cause of death in men with prostate cancer (PCa), the most
common male cancer in the US. With substantial advancements in PCa care, men with non-metastatic PCa have
high 5-year cancer survival rates exceeding 99%. However, in this older male population, non-PCa specific
comorbidities are widely prevalent. CVD results in a 1.5-fold greater risk of mortality than PCa itself, accounting
for 23% of all deaths. The increased risk of CVD in PCa is due to the high burden of cardiovascular risk factors,
prevalent CVD, and exposure to androgen deprivation therapy (ADT). The consequences of these co-morbidities
and toxicities in the aging male are that the oncologic benefits of ADT may be outweighed by the substantial
CVD risk. To enhance the overall health of men with PCa, we need to effectively understand and manage CVD
risk. However, current CVD risk stratification tools, including the widely used ACC/AHA Pooled Cohort Equation
(PCE) and most current AHA PREVENT, perform poorly in cancer patients as they do not consider critical
determinants of CV risk in cancer, such as ADT, the social determinants of health, or the competing risks of PCa-
and non-CVD related mortality. Our long-term goal is to improve upon the overall health outcomes of men with
PCa through risk-based CVD management, i.e. tailoring the intensity of CVD prevention and management to the
individual patient risk. The overall objective of this R01 proposal is to develop accurate CVD absolute risk
prediction models in men with PCa and determine their clinical impact. Our rationale is that current clinical CVD
risk prediction tools, developed in non-cancer populations, are fundamentally limited, as they do not incorporate
cancer-specific variables, cardiotoxic cancer treatment, or emerging predictors of growing importance, such as
the social determinants of health (SDOH). They also do not account for competing risks. The following Specific
Aims are proposed: Aim 1: Develop a well-phenotyped, population-based cohort study by augmenting,
harmonizing, and validating EMR data from a large, diverse health system (Penn) with SEER-Medicare and
medication data (Part D). Aim 2: Derive and externally validate PCa-specific, accurate CVD absolute risk
prediction models that incorporate individual patient characteristics, SDOH, clinical and cancer treatment
information. Aim 3: Evaluate the impact of model implementation on patient health outcomes using plasmode
simulation studies. The expected outcome is a PCa-specific, practical CVD absolute risk prediction tool that can
readily be implemented into clinical care. Moreover, our overall strategy in building a robust cohort study to
enable accurate absolute risk modeling is highly generalizable to other cancers. This work will have an important
positive impact, as it will develop a key risk assessment tool that will advance the overall health of men with PCa
and establish a paradigm-shifting, highly rigorous scientific approach widely adaptable to all cancer populations.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is the leading cause of death in men with prostate cancer (PCa), the most common male cancer in the US. The overall objective of this multi-PI proposal is to develop robust, accurate and precise CVD risk prediction tools that account for the competing risk of PCa mortality and incorporate cancer, CVD-specific, and individual patient characteristics, including the SDOH.